Administrative and Biostatistics

The function of this core is to provide administrative coordination and statistical support of the entire program, including: arranging meetings, handling budgets and procurements, assisting with preparation of manuscripts and progress reports, and maintaining liaison between the numerous groups interacting in this Program. Dr. Madsen will have primary responsibility for coordinating the program, along with Dr. Cosimi, who will oversee interactions among the individual projects. In these positions, Drs Madsen and Cosimi play active and important roles and will be assisted by Ms. Karla Stenger, who will have daily administrative responsibility for the program. Dr. Shoenfeld will review all statistical tools and analyses in the Program.